Integrative Omics Facility Core

The Omics Facility Core (OFC) assists members in fulfilling the mission of SWEHSC to understand the
mechanisms underlying environmental health science (EHS) risks and disease among people living in arid
environments by providing high-quality, cost-efficient access to knowledgeable scientists and a full spectrum of
modern technologies and techniques. The technologies and techniques within the OFC are used to measure
environmental toxicants (exposomics) and their effects on the proteome, metabolome, epigenome, and genome
of exposed populations and laboratory models. The OFC is composed of three labs: 1) an exposomic lab
providing services to quantitate organic and inorganic toxicants of relevance from diverse matrices such as
water, air, dust, bodily tissues, and plants; 2) the proteomics lab providing protein identification, mapping posttranslational
modifications, disulfide linkage characterization, peptide sequencing, and biomarker quantitation;
and 3) a genomics lab providing next-gen DNA sequencing of whole genomes, exomes, and transcriptomes
(RNA-seq), real time RT-PCR, genotyping, fragment analysis, and Sanger sequencing. Finally, epigenomic and
metabolomic services including analysis of histone protein modifications, DNA methylation, and quantitation of
toxicant metabolites are distributed across the three Omics laboratories based on the analyte and expertise
required. The OFC provides Center investigators with prioritized access to state-of-the-art equipment and
approaches to achieve the environmental health science (EHS) goals of the SWEHSC. The three Co-Directors
of the OFC component labs guide the choice of appropriate analysis, consult on experimental design, manage
the analyses and related budget, provide logistical support, provide data interpretation and insight into results,
and assist with dissemination of results. Further, the OFC provides training and education to Center investigators’
staff and students to 1) provide access to modern analytic techniques, 2) consult in experimental design and
efficient use of resources, 3) ensure services are current through technique development and new equipment
acquisition, 4) provide data analysis and interpretation, and 5) assist in the preparation of manuscripts and grant
applications. Integration with other SWEHSC resources facilitates the acquisition of omics-level data and
information that are necessary to fully determine the sites and modes of toxicant action.